MASS SPECTROMETRY CLINICAL RESEARCH RESOURCE

This program provides training, technical assistance, and instrument access for clinical investigators who wish to utilize gas chromatography-mass spectrometry in their clinical research.